Actin cytoskeleton regulation of lens architecture, transparency and mechanics

Project Summary
Lifelong lens transparency and flexible shape, required for focusing light onto the retina, relies upon epithelial
and fiber cells whose shapes and organizations depend on filamentous (F-) actin networks. Epithelial cells
contain three distinct F-actin networks: lateral cell junctions, basal stress fibers, and unique apical polygonal
arrays. These networks consist of tropomyosin (Tpm) isoforms that stabilize F-actin, as well as non-muscle
myosin IIA (NMIIA), and are thought to generate contractile or tensile forces to stabilize epithelial deformation
and integrity during whole lens shape changes, but this has not been tested. Epithelial cells differentiate into
long, thin fiber cells that form complex membrane interlocking protrusions and paddle-like domains that change
with maturation and depth. Fiber cell membrane protrusions are supported by F-actin networks stabilized by
fiber cell Tpm3.5, which regulates F-actin cross-linkers. In Tpm3.5-depleted lenses, the flexible crosslinker, a-
actinin1, is increased on membranes, whereas the stiff crosslinker fimbrin (plastin) is decreased. Tpm3.5-
depleted lenses have decreased whole lens stiffness and resiliency suggesting that more flexible F-actin
networks allow greater fiber cell membrane deformation to result in softer lenses. However, the mechanistic
links between F-actin networks, membrane deformation, cellular architecture, and whole lens shape change
are unclear. The objective of this proposal is to determine how the F-actin networks in epithelial and fiber cells
control membrane deformations and cellular shapes to confer whole lens transparency and flexibility. To
address this, we will use mouse lenses to test gene function and primate lenses as a model for human lens
shape change. Aim 1 will test the hypothesis that distinct F-actin and NMIIA networks control epithelial
deformation and stability during whole lens shape changes. Tpm isoforms associated with epithelial F-actin
networks will be determined, and fluorescent-tagged Tpms, F-actin, NMIIA and cell membranes visualized by
live cell confocal microscopy to investigate network dynamics and cell deformation during whole lens shape
changes. F-actin network functions will be targeted by pharmacological (mouse and primate) or genetic
(mouse) approaches. Aim 2 will test the hypothesis that Tpm3.5-regulated F-actin networks in fiber cells confer
membrane deformation and lens flexibility in a depth-dependent fashion during whole lens shape change.
Fiber cell shape deformations under mechanical strain will be visualized by multiphoton imaging of fluorescent-
labeled membranes in live lenses (mouse), membrane structures examined by scanning electron microscopy
of lenses fixed under deformation (mouse and primate), and whole lens stiffness measured as a function of
lens age. This work will elucidate the fundamental basis by which F-actin networks establish lens epithelial
stability and fiber cell deformability to sustain lifelong lens transparency and flexibility. Identification of
molecular targets in F-actin networks that control lens flexibility will provide candidates to devise future
strategies to mitigate age-related cataracts and presbyopia, which is linked to age-dependent lens stiffening.

Public health relevance
Project Narrative The eye lens is a transparent organ responsible for fine focusing of light onto the retina. Two common age- related lens pathologies are: 1) cataracts, defined as any opacity in the lens, a leading cause of blindness worldwide and 2) presbyopia, a reduction in the lens' ability to change shape during focusing, which is linked to age-dependent increases in lens stiffness. This project will use a multiscale integrative approach to determine the fundamental mechanisms by which molecular regulation of actin filament networks controls nanoscale membrane structures and microscale cellular shapes and deformability, to establish macroscale biomechanical properties and transparency in genetic (mouse) and physiological (primate) models for the human lens.